Bright IDEAS-Young Adults: Problem-Solving Skills Training to Reduce Distress among Young Adults with Cancer

Project Summary/Abstract
Young adults with cancer experience more emotional distress and greater impairments in health-related
quality of life (HRQOL) than older patients. Cancer diagnosis during young adulthood interferes with participation
in normal developmental tasks such as obtaining higher education, starting a career, establishing financial
independence, and developing romantic partnerships. This disruption in normal activities coupled with the
unfamiliar and challenging demands of cancer treatment results in emotional distress and reduced HRQOL.
There is an urgent and critical need to develop, test, and implement evidence-based interventions to support
these young adults as they navigate perhaps the most challenging and debilitating period of their lives.
Current psychosocial care does not adequately address the unique concerns of young adults. An optimal
solution would give young adults the skills to deal with diverse and numerous stressors, address underdeveloped
problem-solving ability characteristic of this age group, and be relatively simple to learn and use during the highly
stressful time following a diagnosis of cancer. To address these clinical care gaps, the parent award is evaluating
the efficacy of a problem-solving skills training intervention developed specifically for young adults and grounded
in the core tenets of problem-solving therapy. “Bright IDEAS-Young Adults” (Bright IDEAS-YA) draws upon and
notably extends prior research demonstrating the efficacy of a cognitive-behavioral problem-solving skills training
program for reducing emotional distress in caregivers of pediatric patients. Bright IDEAS-YA is a 6-session, one-
on-one intervention that teaches patients a systematic approach to overcome personal challenges across any
life domain. It aims to enhance patients’ problem-solving ability in the face of significant stressors such as cancer.
In preliminary work, young adults with cancer found Bright IDEAS-YA acceptable, relevant, and useful. Patients
who received Bright IDEAS-YA showed improvements in problem-solving ability and reductions in symptoms of
depression and anxiety. In the parent award, we are currently conducting a multi-site randomized controlled trial
of Bright IDEAS-YA compared with enhanced usual psychosocial care with 344 YA patients (ages 18-39 years)
undergoing cancer treatment. We will evaluate efficacy and examine mediators and moderators of intervention
effects using assessments at baseline, post-intervention (3 months), and follow-up (6 and 12 months). In the
proposed extension period, we will evaluate the sustainability of intervention effects by extending the follow-up
to 2-years post-enrollment; identify barriers and facilitators of integrating Bright IDEAS-YA into clinical practice;
and address barriers to access by culturally and linguistically translating for Hispanic young adults.

Public health relevance
Project Narrative Young adult cancer patients experience more distress and greater impairment in health-related quality of life compared with older patients, but current psychosocial care does not address their unique needs. The proposed randomized trial will evaluate a novel problem-solving skills training intervention designed to enhance patient problem-solving ability, reduce distress, and improve health-related quality of life. Results will advance clinical practice to reduce the cancer burden among this vulnerable group.